Mitochondria-SR Tethering: Its Role in Cardiac Bioenergetics and Ca2+ Dynamics

This MPI proposal has the overarching theme that mitochondrial Ca2+ uptake plays dual “ying-yang”
roles when the heart is under stress: it ensures that extra energy demands are met under workload stress,
while it is the route for Ca2+ overload/toxicity under oxidative stress. The project uses a new conditional knock-
out rat model for EMRE/Smdt1, an essential subunit of the main mitochondrial Ca2+ uptake system, the mito-
chondrial Ca2+ uniporter channel complex (MCUC). The excitation-bioenergetics (EB) coupling is a signaling
loop that uses the Ca2+ released by sarcoplasmic reticulum (SR) to activate MCUC and generate mitochon-
drial matrix Ca2+ signals to upregulate ATP production. Our long-term goal is to translate the fundamental
mechanism of EB coupling to health and disease of the heart. Our previous work demonstrated that MCUC is
recruited to hotspots at the mitochondria-SR (Mito-SR) contacts to effectively mediate EB coupling by a yet
unknown mechanism.
This proposal aims to address the following gaps in our knowledge about EB coupling:
i). The role of MCUC in cardiac stress tolerance, diastolic dysfunction and heart failure with preserved ejection
fraction (HFpEF). ii). Molecular mechanisms, protein-protein interactions of MCUC recruitment to hotspots at
Mito-SR contacts. iii). How are organelle dynamics (contact formation, fusion/fission) integrated with the dy-
namics of Ca2+ transport distribution? iv). The role of a dominant negative subunit MCUB in the MCUC hotspot
formation, control of the inactive and activatable MCUC channel pool distribution to attain balance between EB
coupling and Ca2+ toxicity.
The Central Hypothesis is that the dichotomy of mitochondrial Ca2+ in controlling health and disease of
cardiomyocytes hinges on the crucial role of EMRE and MCUB in regulating the location and quantity of func-
tional MCUC; this elaborate regulation is critical in cardiac adaptation to “fight or flight” and oxidative stress re-
sponses. Three specific aims are set up to test this hypothesis:
Aim 1. Assess the regulation of EB coupling by MCUC during “fight or flight” sympathetic stress and determine
if cessation of this function could lead to diastolic dysfunction or HFpEF.
Aim 2. Elucidate the molecular mechanism of the MCUC hotspot recruitment in the rat cardiomyocytes.
Aim 3. Study the dynamic interactions between EMRE, MCU and MCUB in regulating the MCUC localization
to maintain EB coupling efficiency while preventing Ca2+ toxicity under pathological stresses.
Completion of the proposed studies will generate a new paradigm for the regulatory mechanisms of mi-
tochondrial Ca2+ in cardiac energetics. The new findings will provide mechanistic basis for a new therapeutic
strategy to treat heart failure.

Public health relevance
Project Narrative The role of mitochondrial calcium uniporter complex in the regulation of cardiac function and energetics in rat remains unknown. This proposal intends to fill this knowledge gap. We will use a rat model that is genetically altered in cardiac specific mitochondrial calcium uniporter complex to obtain mechanistic insights into the regulation of this complex under healthy and failing heart. The findings from the proposed studies will provide novel insight for developing new therapeutic strategy to ameliorate cardiac injury and heart failure.